Characterizing the Neonatal Nasal Microbiome Following a Parent-to-Child Nasal Microbiota Transplant

Project Summary
Staphylococcus aureus (S. aureus) is a common pathogen causing healthcare associated
infections (HAI) in neonates. An estimated 2-3% of very low birth weight infants develop S.
aureus bloodstream or central nervous system infections with an overall mortality of 10-25%.
During delivery or after birth, S. aureus can transfer from people or the environment and
asymptomatically colonize neonates, primarily in the anterior nares. S. aureus colonization is a
well-established predisposing factor to invasive, life-threatening infection, with up to one third of
S. aureus colonized neonates in the neonatal intensive care unit (NICU) developing a S. aureus
infection. Recently, we characterized the nasal microbiome of neonates in the NICU and found
that neonates with S. aureus bloodstream infections had an increased relative abundance of S.
aureus sequences in nasal swab samples and lower alpha and beta diversity measures
compared to neonates with and without S. aureus colonization. These data suggest that a more
diverse bacterial community may promote colonization resistance to S. aureus and protect
against infection. Our long-term goal is to develop paradigm-changing interventions to prevent
life-threatening S. aureus infections in neonates. Recently under an FDA IND, we launched two
pilot placebo-controlled trials to test the safety and feasibility of the first-ever parent-to-child
nasal microbiota transplant (NMT). Using stored samples collected during these pilot trials, we
propose to determine whether bacteria from the parent anterior nares can be transferred to and
seed the neonate's nares, engraft in the neonatal microbiome, and increase neonatal nasal
microbiome diversity. Our specific aim is to characterize the neonatal nasal microbiome
following a parent-to-child NMT. Using samples collected from parents, neonates (prior to and
periodically after NMT), and environmental controls, we will perform shotgun metagenomic
sequencing to characterize and compare the nasal microbiome of neonates who received NMT
or placebo. This study will characterize a novel strategy to assess the biologic plausibility of an
NMT. Findings from this work will inform future studies in children and adults to manipulate the
nasal microbiome as a strategy to prevent S. aureus colonization and disease.

Public health relevance
Project Narrative Staphylococcus aureus (S. aureus) is a leading cause of healthcare associated infections in critically ill neonates. S. aureus colonizes the anterior nares and predisposes to invasive infections. This application proposes to analyze existing samples to determine whether non- pathogenic bacteria from a parent's anterior nares can be transferred to their neonate's nares, engraft in the neonatal microbiome, and increase neonatal nasal microbiome diversity in hope of promoting resistance to S. aureus colonization.